Career Development Program

The goal of the Career Development Program of the UAB Breast SPORE is to recruit basic and clinical investigators who are early in their career for pursuit of translational breast cancer research. The program is primarily composed of young investigators with a junior faculty position in an appropriate basic science or clinical department and are incorporated into the ongoing research efforts of the DAB Breast SPORE under the supervision of an experienced mentor. Hence, the awardee will be exposed to and participate in the interdisciplinary and translational research emphasis of the SPORE. Less commonly, the recipient may be an individual at a more senior level with a successful research record, who wishes to alter his/her career path to translational research. During the time span of the award, the awardee will seek other career development awards and grant support so that he/she can establish an independent research effort, thereby expanding the UAB Breast SPORE translational research effort.